NORC - admin supplement

PROJECT SUMMARY/ABSTRACT (PARENT GRANT)
The role of the Pennington/Louisiana Nutrition Obesity Research Center (NORC) is to promote, facilitate and
enhance collaborative and multi-disciplinary interactions to foster new research ideas and programs in nutrition
and obesity. In doing so, the NORC facilitates and enhances the translation of basic nutritional research findings
into the clinical arena and ultimately into practical applications. Since its inception in 2005 and now in its 4th 5-y
cycle, our research base funding has steadily grown to >$44 million per year in direct costs and 146 members
including 63 Regular Members (part of the research base funding), 70 Collaborating Members (collaborate with
our regular members) and 13 Mentored Members (Early-Stage Investigators working under the mentorship of
NORC members). The Center provides a stable administrative infrastructure and exemplary facilities. NORC
members have access to three state-of-the-art biomedical cores to conduct their research with the highest
rigorous standards; a “Human Phenotyping Core”, a “Molecular Mechanism Core” and an “Animal Model
and Phenotyping Core”. Moreover, our vibrant and successful Pilot & Feasibility Grant Program provides
Early Career Investigators with seed funding to jump-start innovative research programs and generate the
necessary preliminary data for larger grant applications. We just awarded this month (May 2023) three new P&F
grants. Finally, our NORC Enrichment Program provides outstanding training opportunities and mentoring
activities to junior scientists which extends to nutrition and obesity researchers across the entire state of
Louisiana. The central theme of our NORC is “Nutrition, Obesity and Metabolic Health through the
Lifespan”. To impact the prevention and treatment of obesity and its metabolic complications across the
lifespan (from maternal nutrition to older age physical/cognitive functionality) through better nutrition, lifestyle
modifications, and medical treatments, we have developed three translational research teams. These
Translational Research Teams will address big research questions from the basic science level to clinical
investigation and finally implementation to the population. After 15 years of operation, the Pennington/Louisiana
NORC with unwavering institutional support has never been as well positioned to advance the science of
nutrition and obesity on so many fronts and to foster the next generation of leaders in this field.

Public health relevance
PROJECT NARRATIVE Obesity and the resulting metabolic consequences are major drivers for the development of type 2 diabetes mellitus and considerably increase risks for cardiovascular diseases, non-alcoholic fatty liver disease, sleep apnea, many forms of cancers, and other chronic diseases. The Pennington/Louisiana NORC is formulated around three scientific cores that create opportunities to perform innovative research with a true potential to advance the field of “nutrition, obesity, and metabolic health through the lifespan”. The purpose of this supplement is to provide 1-year salary support for Dr. Ursula White (15%), an early career scholar from Pennington Biomedical, who will continue to work with Dr. Fatima Cody Stanford and the trans-NORC Diversity, Equity, and Inclusion Working Group to implement programs and initiatives that increase the inclusion and success of URiA scientists conducting nutrition and obesity research.